Core C: Molecular Targets

ABSTRACT
Core C (Chow, Petricoin) Molecular Targets
The Molecular Targets Core is a multi-functional core. The Core provides a collection, tracking, storage, and
distribution point for biological samples and is a resource and service for carrying out the necessary laboratory
analyses proposed in this application. Furthermore, the Molecular Targets Core is an essential component of
the Program Project in that it allows the Projects to address Specific Aims in a consistent, reproducible, and cost-
effective manner with regards to the identification of molecular markers. The Core will interact in a significant
manner with all Projects and the other cores. Additionally, the Core has put into place detailed forms and SOPs,
and is an essential resource for development of clinical and murine protocols as well as sample management
for a continually growing biospecimen repository. In collaboration with the Biostatistics Core (Core B), Molecular
Targets Core will carry-out sample analyses and interact with each Project on the transfer and/or analysis of
samples, as well as on the management and interpretation of the results. The Core provides
immunohistochemical method development and analysis. The Core also provides Reverse Phase Protein
Microarray (RPPA), a multiplexed quantitative measurement of multiple signaling proteins, many of which are
phosphoproteins, from biological specimens. RPPA represents a novel means of quantitative measurement of
hundreds of proteins from a single specimen.

Public health relevance
PROJECT NARRATIVE Core C (Chow, Petricoin) Molecular Targets The Molecular Targets Core is an essential component of the Program Project. It will provide standardized procedures for sample collection and processing and serve as a collection, tracking, storage, and distribution point for biological samples. It is a resource and service for carrying out the necessary biomarker analyses proposed in this application.